CalRepository: A database of indirect calorimetry experiments for the study of energy homeostasis

Project Summary
A data repository capturing the inputs leading to body weight regulation in disease states is a much-needed
resource in the biomedical community. The sheer volume of data recording food intake, metabolic rate, and
physical activity is overwhelming. Currently, there is no place for researchers to deposit or locate relevant data.
This proposal seeks funding to create a comprehensive and user-friendly data repository that will enable
researchers to deposit their data as well as easily find and re-use, reanalyze, and review energy metabolism
data from scientists worldwide.
The data repository will include any experiment involving indirect calorimetry in rodents. Data will be available
from studies on the effects of altered behaviors (such as hunger, sleep patterns, and exercise) on body weight,
and studies on the role of various disease states in body weight regulation. It will also include experiments
interrogating pathological states including cardiopulmonary disorders, aging, and cancer cachexia, which lead
to altered body weight and energy metabolism. By providing a centralized database for these studies, the
repository will facilitate the development of new therapeutic interventions and help researchers to better
understand the complex factors that influence weight gain and loss. This effort will serve as a template for a
future clinical repository for indirect calorimetry or for additional model organisms.
Modern indirect calorimetry systems allow for high-frequency multi-dimensional time-series measurements of
the components affecting energy balance—food intake, physical activity, and metabolic rates. Our group is at
the forefront of efforts to simplify and standardize these types of data using a free online tool, CalR. However,
no data repository for these types of experiments currently exists. Until this situation is remedied, NIH-funded
investigators are not able to comply with the 2023 NIH Data Management and Sharing Policy. We describe the
creation of the CalRepository designed specifically to facilitate FAIR data principles. Large-scale analysis and
re-use of these types of data will enable new insights into the complexities of body weight regulation.
In summary, the creation of a data repository focused on body weight regulation is essential to effectively
manage the rapidly growing volume of data on this topic and to facilitate the development of new insights
leading to therapeutic interventions. We believe that this project has the potential to significantly advance our
understanding of body weight regulation and improve the health and well-being of individuals around the world.

Public health relevance
Project Narrative We propose to develop a data repository for studying the factors influencing metabolic rate, food intake, and body weight in laboratory animals. The NIH requires investigators to share their data, however, an appropriate data repository does not exist yet. Analysis of these data will provide new insights into the factors influencing body weight.